Ultrastructural alterations to neuronal autophagy during aging delineated with Cryo-EM tomography

PROJECT SUMMARY/ABSTRACT
Misregulation of autophagy has been implicated in aging and age-related neurodegenerative disorders.
Despite its importance, relatively little is known about autophagy in neurons, especially in the context of aging.
This gap in knowledge has prevented understanding how neuronal autophagy helps maintain neuronal
homeostasis and function during aging. The long-term goal is to elucidate the molecular mechanisms that
regulate neuronal autophagy during aging to identify potential therapeutic targets for neurodegenerative
diseases and age-related cognitive decline. The overall objective of this application is to interrogate how age
produces ultrastructural alterations to neuronal autophagosome formation and maturation that ultimately
disrupt nervous system function. The central hypothesis is that in neurons, aging results in defects in
autophagic vesicle ultrastructure and disrupts spatial relationships with neighboring subcellular structures.
Further, failure to form productive autophagosomes leads to an accumulation of unsequestered and
undegraded cargo in the axons, ultimately resulting in loss of neuronal homeostasis and function. The rationale
is that elucidating age-related ultrastructural changes to autophagic vesicles in neurons will provide a
foundation to interrogate the intervention point in the neuronal autophagy pathway to halt or reverse age-
induced loss of neuronal health and function. The central hypothesis will be tested by accomplishing two
specific aims: 1) compare the ultrastructural features of axonal autophagic vesicles during aging using
correlative light and electron microscopy (CLEM); and 2) determine the ultrastructural basis for WIPI2 rescue
of autophagy defects in aged neurons. In the first aim, cryo-electron tomography (cryo-ET) will be used to
elucidate how aging induces ultrastructural changes to autophagic vesicles in mammalian neurons.
Additionally, how aging modulates the architecture of the axonal compartment and the spatial relationships
between autophagic vesicles and neighboring organelles will be quantified using cryo-ET. For the second aim,
the complementary approaches of multi-color live-cell microscopy and cryo-ET will be leveraged to quantify
how ectopic expression of a single autophagy component, WIPI2, rejuvenates the axonal compartment and
restores autophagosome biogenesis in aged mice. The research proposed in this application is innovative
because it utilizes live-cell imaging combined with CLEM to ask how aging modulates the autophagic pathway
and alters the sub-cellular ultrastructure in primary murine neurons. The proposed research is significant
because it is expected to identify stages of neuronal autophagy that are potential targets for intervention to
prevent neuronal decline. Ultimately, the knowledge generated by this proposal has the potential to provide
new opportunities for the development of innovative therapies to delay age-related cognitive decline and
neurodegeneration.

Public health relevance
PROJECT NARRATIVE Misregulation of autophagy has been implicated in aging and age-related neurodegenerative disorders. To understand how age-related misregulation of autophagy contributes to loss of neuronal function during aging, this proposal will elucidate how aging contributes changes in the ultrastructure of autophagosomes in neurons. Thus, the proposed research is relevant to public health and the part of the NIH’s mission that pertains to reducing illness and disability by identifying ultrastructural alterations in neurons during aging.